Trauma exposure, emotion regulation and cognitive skills in early childhood: Prospective and longitudinal examination of the mechanisms of adjustment

Project Abstract An administrative supplement is requested to address data losses during the recent Covid19 pandemic and to longitudinally assess Covid19-specific and race-related trauma exposure in the parent sample (Trauma exposure, emotion regulation and cognitive skills in early childhood: Prospective and longitudinal examination of the mechanisms of adjustment (PAIR Project, RO1MH079252, PI: Jackson). The experience of trauma, especially chronic trauma, and how it impacts developing systems in children as well as parent-child relations has perhaps never been more important than now in the current climate of racial tensions and nationwide Covid19 experiences, which are disproportionately and most severely affecting the most disadvantaged populations, like the participants in our project. An administrative supplement is requested to meet 2 objectives: a) mitigate the negative impact the pandemic has had on the project so that it can meet the study aims, and b) expand the objectives of the project to include a systematic and thorough analysis of the impact of the pandemic and race-related stressors on low income, high historically adversity exposed preschool-age youth and their families. The supplement will allow the project to complete data collection on the remaining T4 participants and allow the project to meet the study aims as a full cohort of participants are required to test the theoretical models of the process of trauma exposure on youth and families. The supplement will also support a second data collection of a large subset of the sample who have completed one time point of a comprehensive assessment of the impact of Covid19 and race- related trauma on themselves and their children. This assessment is well within the scope of the original study as it provides extensive assessment of trauma exposure -the main aim of the parent project. Given the disproportionate impact of Covid19 and race- related trauma on disadvantages samples like the one represented by over 300 families in the parent project, it is critical that we take the opportunity to extensively measure not only the experiences of the sample related to Covid19 and race-related traumas, but to follow them over time to determine the trajectory of youth and parent health. Moreover, the assessment supported by the supplement will identify possible mechanisms of impact, such as health behaviors, trust in medical information, and access to health care — all of which could serve as possible effective intervention points for the sample and will provide lessons for intervention for future pandemics.

Public health relevance
Project Narrative The administrative supplement will be used to address project losses due to Covid19 pandemic and to measure Covid19-specific trauma and race-related trauma as a result of recent events over the past year that have led to unique and unprecedented trauma exposure for the participants of the parent project (Trauma exposure, emotion regulation and cognitive skills in early childhood: Prospective and longitudinal examination of the mechanisms of adjustment (PAIR Project, RO1MH079252). The supplement will allow for longitudinal assessment of Covid19 and race-related trauma over time and comparison with already measured chronic trauma exposure and health outcomes in the parent project's mostly African American sample to identify unique contributions of new events on preschool-age youth and parents and possible mechanisms for intervention.